Defining the Biological Arc of Grade Group 1 Prostate Cancer

The long-term goal of this project is to further reduce the biological uncertainty associated with surveillance for
favorable-risk prostate cancer. Although most men with favorable-risk disease are candidates for surveillance,
its use varies widely and ranges from 20 to 90% across individual providers. A major barrier to implementation
by providers, and acceptance by patients, relates to uncertainty around the biology of Grade Group 1 (GG1;
Gleason 6) prostate cancer. Key unresolved questions include: Does GG1 prostate cancer progress over time?
Does GG1 cancer share molecular origins with higher-grade disease and lymph node metastases? Are there
molecular features of GG1 tumors that predict the presence of synchronous, but undetected, higher-grade
disease elsewhere in the prostate? Is GG1 cancer more aggressive in African Americans? To be sure, the
biological trajectory of GG1 prostate cancer represents a critical knowledge gap. We hypothesize that GG1
prostate cancer rarely undergoes clonal grade progression, and that molecular changes in GG1 cancer do not
predict the presence of synchronous higher-grade disease. To test these hypotheses, we propose the following
aims: 1) to determine if high-grade prostate cancer arises clonally from GG1 prostate cancer in men on
surveillance over time, 2) to molecularly dissect GG1 prostate cancer both within and without the context of
synchronous grade discordant multifocality, and 3) to interrogate primary multifocal prostate cancer for shared
clonality between GG1 and higher-grade disease/lymph node or distant metastases. The successful
completion of the aims of this project will alter the way men with GG1 prostate cancer are clinically managed
by further reducing uncertainty about the clinical and molecular arc of favorable-risk disease. Practically, these
findings have the potential to provide confidence to providers and patients when selecting surveillance for GG1
prostate cancer by reducing concerns over clonal disease progression and by shedding light on the likelihood
of co-existing higher-risk cancer that has yet to be detected—factors that play key roles in the selection and
effective implementation of surveillance. Our research team composed of experts in prostate cancer
management, molecular profiling, and bioinformatics, coupled with our distinctive and extensive access to
relevant tissue resources, is uniquely poised to complete our research plan.
PHS 398/2590 (Rev. 6/09) Page Continuation Format Page

Public health relevance
The goal of this project is to define the biological fate of low risk (Grade Group 1) prostate cancer in both African and European Americans. This project will allay patient concerns related to disease progression and the presence of co-existing higher-grade cancer—factors that play central roles in the safe and effective implementation of surveillance. Ultimately, findings from this research will enhance patient selection for surveillance and inform how to improve the quality of its implementation.